Mechanisms of VP4 Promoting Rotavirus Cell-to-Cell Transmission and Viral Pathogenesis

Project Summary
Viruses spread from infected cells to uninfected “bystander” cells by two fundamentally distinct modes, by
releasing into extracellular environment or by direct cell-cell contact. For enteric viruses, which are mostly non-
enveloped viruses, the current paradigm is that they predominantly egress host cells via an extracellular
manner, either as naked cell-free viruses or in membrane-associated forms. Whether enteric viruses can
efficiently spread through cell-to-cell transmission has not been studied.
Rotaviruses (RVs) are highly pathogenic human viruses that infect intestinal epithelial cells (IECs) and
cause more than 200,000 children deaths every year. RV infections are also associated with severe diarrheal
diseases in the elderly and immunocompromised. The current RV vaccines are significantly less effective in
low-to-middle-income countries. There is also a lack of RV-specific and broad-spectrum anti-enteric virus
therapeutics. In a recent proteomics study from our laboratory, we found that the RV outer capsid protein VP4
co-precipitates with multiple subunits of the actin-related protein 2/3 (Arp2/3) complex. IEC-intrinsic Arp2/3
mediates the migration of IECs from crypts towards the top of the intestinal villi. However, the role of Arp2/3 in
enteric virus infections is not known. Our new preliminary data suggests that RV cell-to-cell transmission was
defective in CRISPR/Cas9 knockout cells that lack Arp2/3 subunits. In addition, chemical inhibition of Arp2/3
activity significantly reduced RV fecal shedding and diarrhea in a neonatal mouse model of RV infection. RV
replication was also attenuated by Arp2/3 inhibition in fully differentiated human intestinal organoids. We
hypothesize that VP4 protein binds and co-opts the host Arp2/3 complex in the infected IECs to enable
RV cell-to-cell spread, which contributes to viral replication and pathogenesis.
To test this hypothesis, we will leverage our expertise in RV reverse genetics systems, a highly tractable
mouse model of RV diseases, and state-of-the-art biochemical and imaging techniques. In Aim 1, we will use
hydrogen-deuterium exchange mass spectrometry and proximity ligation assays to determine the biochemical
properties, subcellular localization, and timing of VP4-Arp2/3 interactions during RV infection. In Aim 2, we will
investigate the physiological relevance of the Arp2/3 complex in RV infection in vivo using conditional knockout
mice, 5-ethynyl-2-deoxyuridine labeling, and infectious RVs expressing an mScarlet reporter and chimeric
VP4s. Collectively, we expect that this study will establish a new model of a successful enteric pathogen
taking advantage of cell-to-cell transmission in the milieu of the mucus layer in the intestine to
complement the traditional extracellular way of egress. We may also reveal novel mechanisms by which RV
alters the migration patterns of infected and bystander IECs to its benefit. Our findings will be instrumental for
designing new antiviral inhibitors and next-generation live-attenuated RV vaccine candidates based on
targeting VP4-Arp2/3 interactions to alleviate diarrhea and mortality.

Public health relevance
Project Narrative Rotaviruses are among the most important causes of severe diarrheal illness in infants and young children. Our proposed studies of the interactions between rotavirus VP4 and the host Arp2/3 complex will facilitate the rational design of novel vaccines and antiviral therapeutics against rotavirus, thereby reducing the overall infection-associated morbidity and mortality.